Comprehensive and Robust Tools for Analysis of Tumor Heterogeneity and Evolution

This is a collaborative project between Dr. Fei Chen’s IMAT project (R33CA246455) and Dr. Ben
Raphael’s ITCR project (U24CA248453). In this project, we will develop an integrated
experimental and computational platform to analyze the spatial organization of clones in tumor
samples. This platform will combine the Slide-RNA-SeqV2 and Slide-DNA-seq technologies
under development in PI Chen’s IMAT project with customized computational algorithms that
extend the work in PI Raphael’s ITCR project. The proposed work is organized in two aims. In
the first aim, we will extend and optimize computational tools under development in the ITCR
project to identify allele-specific copy number aberrations and spatial distribution of tumor
clones in Slide-RNA-SeqV2 data generated the IMAT project. In the second aim, PI Chen will
generate high resolution spatial DNA data using Slide-seq. This data will uniquely integrate with
computational algorithms from the Raphael group who showed that using allele-specific copy
number aberrations led to much more reliable reconstructions of tumor evolution than total
copy numbers in 10X Genomics whole-genome single-cell sequencing data. The combination of
Slide-RNA-seq data, Slide-DNA-seq data and advanced computational approaches will enable
novel studies of the spatial distribution of clones within tumors and the spatiotemporal
patterns of tumor evolution.

Public health relevance
Project Narrative In recent years precision oncology approaches based on molecular changes in an individual patient’s tumor have emerged as a promising new approach to diagnosis and treatment of cancer. However, these approaches are challenged by the fact that tumors are a heterogeneous collection of cells that change over time and in response to treatment. We will develop advanced software and powerful data analytic tools that will enable researchers to characterize the heterogeneity within tumors with high accuracy, enabling greater precision in cancer diagnosis and treatment.